Project 2: Targeting signaling networks to overcome therapeutic resistance in pancreatic cancer

PROJECT SUMMARY – Project 2: Signaling
Pancreatic ductal adenocarcinoma (PDA) is most commonly diagnosed at late stages, at which time the disease
is refractory to most conventional treatment options. Identifying therapeutic strategies that pre-empt the
development of resistance and achieve durable tumor control has been hampered by the enormous complexity
of the paracrine signaling network in PDA. STAT3 is a major node in this resistance network. The Hunter lab has
shown that production of leukemia inhibitory factor (LIF) by cancer associated fibroblasts (CAFs) is a major driver
of STAT3 signaling in tumor cells and promotes chemoresistance. Further, they have shown that LIF and the
related cytokines IL6 and OSM may also play a role in STAT3 signaling in the immune microenvironment (IME).
In Aim 1, the team will investigate the extent to which induction of STAT3 signaling by these cytokines contributes
to tumor growth and therapeutic resistance. High-resolution spatial profiling and single-cell approaches will be
used to delineate the cell type-specific alterations in STAT3 activation using syngeneic orthotopic models of PDA
following treatment with chemotherapy and blockade of LIF, IL6, and/or OSM, which will be corroborated with
the colocalization of cytokines and STAT3 signaling in human patient specimens. As LIF can activate several
pro-survival pathways, the importance of STAT3-dependent and -independent mechanisms to PDA growth and
chemoresistance will be determined. In addition to chemotherapy, the ability of cytokine blockade to potentiate
immune checkpoint inhibition (ICI) will be investigated. Further, the team has discovered that aberrant
glycosylation can also modulate the STAT3 pathway. Elevation of the glycan CA19-9 in organoids and in vivo
resulted in increased STAT3 signaling in both the epithelial and stromal compartments. In Aim 2, the mechanism
by which CA19-9 elevation activates STAT3 will be determined and the role of this signaling pathway in
chemoresistance will be dissected in a cell type-specific manner using a novel organoid co-culture platform and
a first of its kind genetically engineered mouse model with pancreas-specific KRAS and TRP53 mutations and
inducible CA19-9 expression. In addition to STAT3, CA19-9 elevation promotes receptor tyrosine kinase
signaling, including activation of the EGFR pathway, which also drives chemoresistance. However, inhibition of
either pathway has yielded limited clinical success. The team’s preliminary studies have revealed correlations
between elevated CA19-9, resistance to chemotherapy, and induction of autophagy, a pathway known to
mediate resistance to both chemotherapeutics and targeted therapies. Therefore, experiments proposed in Aim
3 will systematically dissect how CA19-9 modulation of STAT3, EGFR, and autophagy contribute to therapeutic
resistance. It is important to note that most previous mouse studies on these resistance pathways have been
performed in the absence of CA19-9 and that >90% of PDA patients are CA19-9 positive. Advanced organoid
methodologies will be used to investigate both genetic and pharmacologic perturbation of these pathways,
culminating in in vivo explorations of the efficacies of combination treatment strategies in CA19-9-positive PDA.

Public health relevance
PROJECT NARRATIVE – Project 2: Signaling Pancreatic ductal adenocarcinoma is one of the deadliest common carcinomas due, in part, to both inherent and acquired therapeutic resistance engendered by the complex crosstalk between cancer cells and the surrounding microenvironment. We will utilize a combination of in vivo and organoid co-culture models to systematically map the intricate cellular signaling networks that promote PDA survival and treatment resistance. We will then leverage our understanding of paracrine signaling to intercept key hubs in this resistance network using genetic and pharmacologic perturbation.